Effects of Xylazine Exposure on Maternal, Perinatal and Infant outcomes

Overdose deaths among pregnant women who use drugs (PWWUD) account for 1 in 6
pregnancy-associated deaths in the United States. An escalating maternal death rate is largely
due to the use of high-potency synthetic opioids, like illicitly manufactured fentanyl (IMF) and
xylazine has been increasingly identified as an IMF adulterant. Xylazine exposure has been
linked to multiple complications such as severe necrotic wounds and profound sedation but the
additional risks of exposure to xylazine and fentanyl-xylazine combinations in pregnancy on
maternal, perinatal, and neonatal outcomes are unknown.
In 2023, our Perinatal Addiction Consultation and Education Service (PACES) at Magee-Women’s Hospital, the largest maternity hospital in Pennsylvania, noticed a sharp rise in clinical
evidence of xylazine exposure among pregnant patients admitted to initiate treatment with medications for opioid use disorder (OUD). This has posed new challenges related to the initiation and continuation of medications for opioid use disorder (MOUD, e.g. buprenorphine and methadone) which is particularly concerning, as these medications significantly reduce the risk of overdose and preterm birth in pregnant women with OUD.
The goal of this research is to better understand the prevalence and clinical sequelae of xylazine
exposure in pregnancy and explore the effects of xylazine exposure on outcomes among PWWUD and their infants. To achieve this goal, we will conduct a mixed-methods, prospective
cohort study among PWWUD at risk of xylazine exposure and utilize health record (EMR) data,
urine toxicology testing, and person-reported quantitative and qualitative data to (a) comprehensively evaluate and compare differences in healthcare utilization patterns and
outcomes among PWWUD, with and without xylazine exposure, (b) understand the ways in
which xylazine exposure may be shaping the lived experiences of patients, and (c) inform the
development of future interventions to minimize the risk of adverse outcomes associated with
xylazine exposure among pregnant women.

Public health relevance
PROJECT NARATIVE Opioid use disorder (OUD) during pregnancy is a major contributor to maternal, perinatal, and neonatal morbidity and mortality, driven largely by the dominance of high-potency, synthetic fentanyl in the unregulated opioid supply. Xylazine, a veterinary agent not approved for human use, has been increasingly identified as a contaminant in the illicit fentanyl supply but the effects of xylazine exposure during pregnancy have not been studied. This research project will explore the effects of xylazine exposure on maternal, perinatal, and neonatal outcomes and identify opportunities to employ related risk mitigation strategies.